Penn State Clinical and Translational Science Institute

Project Summary The ongoing COVID-19 pandemic has taken a significant toll on the physical, mental, social, and economic well- being for the American people. However, the research of COVID-19 related treatments and outcomes has been hampered by lack of a large-scale, well-coordinated, and readily available clinical data repository. The National Institutes of Health has launched the COVID Cohort Collaborative (N3C) to establish a centralized data repository of up-to-date and curated databases to store vast amounts of electronic medical records from people diagnosed with coronavirus. This central data repository aims to provide rapid, open, secure, and well-managed access for all researchers to study the coronavirus disease, to better understand risk factors, and to develop effective treatments. Penn State CTSI is fully committed to contribute to N3C’s initiatives and has determined to leverage its Patient-Centered Outcomes Research Network (PCORnet) common data model (CDM) to accomplish this goal.

Public health relevance
Project Narrative The ongoing COVID-19 pandemic has taken a significant toll on the physical, mental, social, and economic well- being for the American people. The National Institutes of Health has launched the COVID Cohort Collaborative (N3C) to establish a centralized data repository of up-to-date and curated databases to store vast amounts of electronic medical records from people diagnosed with coronavirus. Penn State Clinical and Translational Science Institute is fully committed to contribute to N3C’s initiatives.